Workplace Harassment, Macro-Level Stressors, Substance Use and Health Outcomes: A Long-Term Follow Up

Workplace harassment (WH) is a traumatic stressor that is consistently linked to substance use and abuse,
poor mental health, and health symptoms. However, long-term risk for serious psychopathology, morbidity, and
mortality remains unstudied. Building on our prior work on WH and substance use, we focus on four aims: 1)
delineate long-term consequences of WH on morbidity and mortality over a 25 year period; 2) using three
approaches, test the role of substance abuse, psychological and cognitive mediators (distress, alienation, and
rumination), and stress sensitization, and the possible integration of these factors, to explain the long-term
effects of WH on psychopathology and adverse health outcomes, including mortality, in the context of other
stressors and key work-related structural and contextual factors; 3) examine risk and protective factors
(services use, coping and coping effectiveness, gender and race/ethnicity) modifying the relationships between
prior and current stressors and substance abuse, psychopathology, and adverse health outcomes, and 4)
examine the reliability of long-term recall of prior WH experiences and substance use by comparing current
recall to prior reports. A central innovation of the proposed study is delineating how WH, a micro-level stressor,
may sensitize reactions to later micro- and macro-level stressors, increasing long-term risk for substance
abuse, psychopathology, and adverse health outcomes. Capitalizing on an existing 8-wave dataset spanning
10 years, this follow-up study will a) re-survey at 3 one-year intervals a cohort of adults first surveyed while
employed in 1996 (N=2478); b) supplement the survey with structured interviews to assess presence and
timing of current and past psychopathology and substance abuse as per DSM-5 criteria, long-term recall of WH
and substance abuse, and work-related structural and contextual factors that contribute to WH; and c) use the
National Death Index to ascertain mortality, including date and cause of death, on mortality occurring since the
end of the prior study. This design will allow us to test longitudinal models of the effects of WH on morbidity
and mortality, incorporating both proximal and distal mechanisms, and incorporating intrapsychic factors,
behavioral factors, and work-related structural/contextual factors in models to explain long-term effects of WH
on outcomes. This will be the first study of long-term risk for mortality associated with WH. Given the wealth of
previous data characterizing the sample, this study presents a unique opportunity to inform viable strategies to
prevent and address WH-related substance abuse, psychopathology, chronic health issues, and mortality, and
to inform targeted, timely treatment and prevention strategies to ameliorate negative health-related effects of
WH at individual, workplace, and policy levels.

Public health relevance
Project Narrative/Public Health Relevance Workplace harassment is a traumatic stressor associated with substance use and health outcomes, but long term risk for morbidity and mortality has not been studied. Determining the mechanisms through which prior harassment exposure increases long-term risk for substance abuse and adverse health outcomes would increase public awareness of workplace harassment as a significant health risk. This project can advance stress theory and help inform the development of targeted prevention and intervention efforts to help reduce harassment-related adverse effects on health.